Novel Mechanisms of Genetic Errors of Immunity

Project Summary: Inborn Errors of Immunity (IEI) collectively comprise more than 500 different monogenic
disorders of the immune system. Primary Immune Regulation Disorders (PIRD) represent a subset of IEI, that
are characterized clinically by a lack of regulation of the immune response resulting in overlapping features of
infectious susceptibility, autoimmunity, lymphoproliferation, inflammation, and/or atopy. While tremendous
advances in patient diagnosis and disease mechanisms understanding have been made, significant gaps in the
field remain. First, the molecular diagnostic rate for all IEI remains only 30-40%, even in multiplex families with
high likelihood of genetic inheritance. Second, most diseases of immune dysregulation have variable penetrance
(i.e, have or don’t have disease) and have variable expressivity (i.e, have mild vs severe disease). This
phenomenon is by and large unexplained. Our emerging data suggests three evolving genetic concepts of
disease including epigenetic, somatic mutations, and genetic modifiers. We propose to use the term Genetic
Errors of Immunity (GEIs) to encompass these broad and novel molecular mechanisms. In Project 1 we will
tackle a novel epigenetic mechanism, where despite heterozygosity on DNA level, transcriptionally only one
allele is expressed in select cell lineages, a phenomenon termed autosomal random monoallelic expression
(aRMAE). We propose to map genes that are prone to aRMAE in the immune system, define epigenetic marks
governing this process, and validate these findings in individuals with identified genetic lesions within families
with known incomplete penetrance. This will allow us to document discrepant genotype to “transcriptotype” and
measure functional implication of this epigenetic phenomenon. In Project 2 we will investigate somatic mutations
as a cause of GEIs, a concept in its infancy. Herein we propose to perform high-depth targeted sequencing to
identify genetic mosaicism in patients with suspected GEI who were negative by standard genetic testing, and
to develop single cell technologies for evaluating their functional impact on the immune response. Our
preliminary data suggests that a mutation causative of PIRD can be both somatic and in a gene undergoing
aRMAE, suggesting clear synergy among Project 1 and Project 2. Finally in Project 3, we will address known
genetic risk variants in tandem with polygenic risk score (both of which would otherwise be clinically silent). This
concept is of great interest in the IEI field. Understanding these modifier genes, whether germline, somatic or
epigenetically regulated (undergoing aRMAE) forms a clear cohesive connection between Projects 1-3. To
support this set of integrated yet distinct projects we propose: 1) an administrative core charged with coordination
of meetings, regulatory compliance, and grant management; 2) Sequencing and sample core: tasked with patient
and control sample WEG, WGS, Targeted Deep Sequencing, RNA Seq, and scRNASeq and 3) Bioinformatics
and computational biology Core tasked with development and integration of bioinformatic pipelines. Combined,
these 3 projects and 3 cores will synergize in defining novel disease mechanisms in GEI.

Public health relevance
Project Narrative: Inborn errors of immunity collectively represent more than 500 different monogenic disorders of the immune system with broad clinical phenotypes. However, genetic diagnostic rate remains only 30-40%, leaving most patients undiagnosed. In this Program, we will address these gaps through integrated research projects and Cores focused on these three distinct, novel concepts of discovering immune related genes undergoing monoallelic expression, identifying somatic drivers of disease, and investigation of inborn and somatic modifiers of disease phenotype.